Administrative Core

Project Summary. The Administrative Core forms the nucleus of the COBRE Phase II Center for
Neuroplasticity at the University of Puerto Rico. As such, it will support the three-fold objectives of the
COBRE Center: 1) Develop and maintain a nationally competitive biomedical research program
focused on the theme of Neuroplasticity; 2) Facilitate the developmental trajectory of junior
investigators toward their transition to independent research careers; 3) Support the COBRE
NeuroImaging and Electrophysiology Facility (NIEF). The Administrative Core incorporates all
programmatic facets of this initiative, including Faculty Career Development Activities (Laboratory
Management, Grant Writing, Manuscript Preparation) and Neuroscience Research Infrastructure
Enhancement programs (Seminar Series, Neuroscientist-in-Residence, Annual Puerto Rico
Neuroscience Conference, Outreach Activities, and Academic Partnerships). The Administrative Core
is composed of a team of individuals with proven track records and experience in the operation and
management of large multi-faceted research and training programs. Oversight of the Core is the
responsibility of the COBRE Associate Director, Dr. Mark Miller. Miller serves as liaison between the
program and its Evaluation Module and he coordinates communication with NIGMS officials. The
Administrative Support Office will continue to be staffed by a highly experienced and dedicated team
including: Ms. Bethzaida Birriel, Grants Administrator; Ms. Brenda Caban, Accountant; and Ms. Sandra
Felix, Purchasing Agent. All fiscal matters will be managed at the Institute of Neurobiology, a free-
standing unit under the Deanship of Academic Affairs of the University of Puerto Rico Medical Sciences
Campus. Institute personnel will handle most aspects of the post-award administration of funds,
including hiring of technicians, postdocs, and students. Finally the Administrative Core will coordinate
all program appraisal and assessment, including the participation of an independent external evaluation
group from Cooperativa de Servicios de Evaluación e Investigación (CoopSEI). The Administrative
Core team will organize the Annual COBRE Retreat and Assessment Activity that will enable all
stakeholders to meet, exchange ideas, report progress, and plan future strategies. This meeting will
serve as the principal forum for developing and disseminating data required for formative and
summative evaluation of all COBRE Center research objectives and programmatic initiatives.